Physiology

Project Summary-Physiology Core
The OVERALL aims of this Vision Research Core (VRC) are to provide:
· access to resources outside the scope of individual R01 awards
· access to technical expertise outside the scope a single laboratory
· staff training to remove barriers to efficient translational research and collaboration
· collaboration initiatives among VRC labs
The research areas supported by the VRC span the analysis and treatments of retinal degenerations,
developmental disorders, glaucoma and other disorders, as well as and a range of cutting-edge basic science
initiatives. We have implemented four resource modules that continue the natural evolution of how this
research group works together, serving 17 investigators holding 22 NEI R01 awards.
The Physiology Module is a powerful set of tools that VRC faculty use for animal model validation and disease
profiling: ERGs, OptoMotry behavioral testing, and a range of ocular imaging tools (OCT, Micron). Our new
module includes in vivo / in vitro 2-photon imaging.
Specifically the Physiology Module provides:
· Three UTAS ERG systems (two within the JMEC vivarium)
· An OptoMotry system within the JMEC vivarium
· Two Micron mouse imaging systems (one within the JMEC vivarium)
· An additional new Micron IV mouse imaging system with high resolution OCT, image-guided ERG
function, slit lamp and focal laser injury submodules, recently acquired with funds from the Department
of Ophthalmology and an Administrative supplement of the NEI (P30EY014800-14S1)
· Rotarod for locomotor and vestibular phenotyping within the JMEC vivarium
· Dual Spectralis OCT systems (one within the JMEC vivarium)
· A Bruker Ultima 2-photon microscope (in core on floor 5)
· Technical support for all these systems